New Proteomic Technologies for the Analysis of Tyrosine Kinase Signaling Pathways

DESCRIPTION (provided by applicant): A key objective of phosphoproteomic analyses is to obtain an in-depth understanding of protein phosphorylation and signaling networks in cells. However, despite the great progress that has been made over the past few years, our ability to analyze such signaling pathways is still greatly limited by a number of serious technical challenges. The long term goal is to develop novel proteomics strategies valuable for understanding on the molecular level the role of phosphorylation in regulating cell proliferation. The objective in this application is to devise and optimize effective and efficient methodologies and strategies for the analyses of tyrosine kinase phosphoproteomes, using a dual functional tyrosine kinase Syk as the model system. This approach will utilize functional, soluble polymers for the efficient and inclusive isolation of phosphopeptides coupled with an integrated chemical, mass spectrometric, and computational strategy for the identification of specific tyrosine kinase substrates and for quantitative phosphoproteomics. We will focus on Syk-dependent signaling and establish protocols that will ultimately provide a powerful method to dissect any signaling pathway regulated by protein-tyrosine phosphorylation. Guided by strong preliminary data, this objective will be achieved by pursuing three specific aims: 1) Develop a proteomic platform for the analysis of protein phosphorylation. We will primarily develop, characterize and optimize functionalized soluble polymers designed for the affinity and chemical isolation of phosphopeptides; 2) Identification of specific tyrosine-kinase substrates and their phosphorylation sites; and 3) In-depth analyses of tyrosine kinase phosphoproteomes in several cancer types. We will develop and apply our quantitative proteomic technologies for the identification and quantification of tyrosine-phosphorylation sites in several cancer types. This project is innovative because it will develop a series of novel analytical techniques to directly identify novel tyrosine kinase substrates and phosphorylation sites that will provide investigators with a significantly expanded capability to dissect signaling pathways. The developed techniques will provide detailed knowledge at the molecular level on precisely how tyrosine kinases are involved in cell signaling under different physiological conditions through dynamic changes in protein phosphorylation. It is also expected that, by identifying a kinase's direct substrates, the proposed research will provide a powerful tool to conveniently map kinase networks.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed studies to develop a series of analytical techniques have potential applicability for investigators in the molecular signaling field. The tools will allow them to examine important roles of tyrosine kinase in multiple signaling pathways. The proposed research will provide unique strategies and materials that will strengthen the important contribution that proteomics can make to our understanding of cancer biology. PROJECT NARRATIVE The proposed studies to develop a series of analytical techniques have potential applicability for investigators in the molecular signaling field. The tools will allow them to examine important roles of tyrosine kinase in multiple signaling pathways. The proposed research will provide unique strategies and materials that will strengthen the important contribution that proteomics can make to our understanding of cancer biology. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Changes in the expression or activity of protein-tyrosine kinases are common characteristics of many disease types. Preclinical and clinical data strongly support the association of elevated levels of tyrosine kinase activity with enhanced cell proliferation, motility and invasiveness. However, one cannot assume a priori that the elevated expression of a tyrosine kinase will be associated with a poor prognosis. The spleen tyrosine kinase Syk, for example, plays distinct roles in different cancer cell types. Syk is overexpressed or activated in some cancers (lymphoma and leukemia, squamous cell carcinoma), yet functions as a tumor suppressor and is down-regulated in others (breast cancer, melanoma). These findings indicate that tyrosine kinases can play very intricate roles in distinct signaling pathways that are fundamental to the development or prevention of cancer. Monitoring general increases or decreases in protein-tyrosine phosphorylation or even the modification of single proteins will likely fail to accurately reflect the critical events that alter the growth properties of cells that lead to more or less malignant phenotypes. In particular, there is a paucity of data regarding how a kinase could achieve such divergent effects on tumor cell growth and metastasis. Thus, a system-wide approach to understanding signaling pathways in different cancer cells is highly desirable. However, despite intense interest, our ability to analyze such pathways is still greatly limited by a number of serious technical challenges. Our long term goal is to develop novel proteomics strategies valuable for understanding on the molecular level the role of phosphorylation in regulating cell proliferation. Mass spectrometry-based proteomics has become the method of choice for unbiased analysis of in vivo phosphorylation and provides a powerful tool for the identification and close examination of phosphoproteins at different states and the determination of quantitative changes in the phosphorylation of individual proteins in a complex mixture, resolved to the level of individual sites. Our objective in this application is to develop effective and efficient methodologies and strategies for the analysis of tyrosine kinase phosphoproteome. This approach will utilize functional, soluble polymers for the efficient isolation of phosphopeptides coupled with an integrated chemical, mass spectrometric, and computational strategy for the identification of specific tyrosine kinase substrates and for quantitative phosphoproteomics. We will test this approach by focusing on Syk-dependent signaling as our model system and will establish protocols that will ultimately provide a powerful method to dissect any signaling pathway regulated by protein-tyrosine phosphorylation. Our specific aims are: Aim #1: Develop a proteomic platform for the analysis of protein phosphorylation. We will primarily develop, characterize and optimize functionalized soluble polymers designed for the isolation of phosphopeptides with high efficiency. Aim #2: Identification of Syk substrates and their phosphorylation sites. Using Syk as our model kinase, we will develop a strategy based on quantitative proteomics for the identification of novel substrates that will be generally applicable to virtually any tyrosine kinase. Aim #3: Profiling Syk-modulated phosphoproteomes in immune and breast cancer cells. We will develop and apply our quantitative proteomic technologies for the identification and quantification of phosphorylation in several cancer types in response to Syk expression. This project is innovative because it will develop a series of novel analytical techniques to directly identify novel tyrosine kinase substrates and phosphoproteomes that will provide investigators with a significantly expanded capability to dissect signaling pathways. At the completion of this project, we expect the following outcomes: first, a general method to efficiently analyze phosphopeptides will have been developed; second, we will have established a proteomics strategy that will be able to provide a quick and direct method to identify tyrosine kinase substrates; third, we will have illustrated the use of these strategies to monitor kinase-dependent changes in phosphorylation in cancer cells. Most importantly, the dynamic phosphoproteomes we will portray at the molecular level have the potential to provide missing links in a global, integrative view of cellular regulation. As a consequence, the results of this study will have an important positive impact, not only on the development of novel tools for biochemical research, but also toward significantly improving cancer therapeutics and facilitating more effective medicine. 3